Nanofiber Patch with Gradient Presentation of Biomolecules for Treatment of Pediatric Tracheal Stenosis

PROJECT SUMMARY
The long-term objective of this application is to bring a trachea patch to the market for treatment of pediatric
tracheal stenosis, or narrowing of the airway, which left untreated can be a life-threatening condition. Currently,
otolaryngologists have only two major options for treating tracheal stenosis. One is a complex surgical procedure
known as slide tracheoplasty that few surgeons in the country are qualified to perform. The other is to cut and
splay the trachea holding it open using a graft of rib cartilage. Both are difficult, time-consuming procedures with
potential complications. We have an issued U.S. patent on the trachea patch biomaterial that overcomes the five
major technical hurdles required to replace rib cartilage grafting: 1) mechanical integrity, 2) suturable, 3)
resorbable, 4) air-tight, and 5) off-the-shelf. There is currently nothing on the market remotely resembling the
idea of a synthetic patch for tracheal stenosis. While the academic tissue engineering community has focused
primarily on regenerating an entire trachea with highly complex strategies, arguably leading to technology in
search of an application, we have focused instead on identifying a specific patient indication with an unmet need
and designed a technology to fill that void.
The overall hypothesis is that mimicking the wound healing environment using reinforced electrospun
scaffolds with gradient presentation of biological factors will maintain tracheal patency and regenerate cartilage-
like tissue comparable to healthy tracheas. Two specific aims are proposed to determine the most attractive
growth factor loading for mimicking specific stages of wound healing. Aim 1 will refine growth factor loading by
evaluating multiple compositions in a subcutaneous model. The final device composition will then be evaluated
in a capstone in vivo rabbit tracheal defect study in Aim 2.
Compared to rib cartilage grafting, our trachea patch holds the following advantages: 1) No surgery to remove
rib tissue, saving operating room time and cost, and eliminating potential complication/infection and morbidity at
the rib site (attractive to patients and insurance companies), 2) Easy to use, as it is “plug and play” for surgeons
who perform rib cartilage grafting (attractive to surgeons), 3) The gradient design has the potential to improve
functionality and accelerate regeneration, promoting vascularization, macrophage recruitment, and directed
matrix synthesis. For several reasons, we focus initial clinical translation on the pediatric population with
laryngotracheal stenosis. In the simplest terms, our goal is to fix tracheas for young children around the world
with narrowed airways to help them survive and breathe normally again.

Public health relevance
PROJECT NARRATIVE The proposed technology will help surgeons to treat young patients who have difficulty breathing due to narrowed airways, a potentially life-threatening condition. Currently, surgeons perform either a very complicated surgery, or they open the front of the trachea with an incision and use rib cartilage to hold the trachea open. The technology is an off-the-shelf trachea patch that will replace the need to harvest rib cartilage, allowing the patient to breathe normally without the need to harvest cartilage from the rib.